VCU Massey Cancer Center Support Grant

Project Summary This supplement application is submitted in response to PA-20-272. Specifically, the application addressed the requested area of research interest ? P30 Administrative Supplement to Cancer Center Support Grant to Strengthen NCI-Supported Community Outreach Capacity through Community Health Educators of the National Outreach Network.” The Virginia Commonwealth University Massey Cancer Center (MCC) administrative supplement application builds on the Parent Cancer Center Support Grant’s Aim 1 (to advance impactful scientific discovery) and 3 (to reduce risk, occurrence and suffering due to cancer. This application builds on and extends past program successes. Over the past 8 years, the MCC National Outreach Network Community Health Educator (NON CHE) has focused outreach and education activities on the city of Petersburg, which lies within the service area of MCC. These efforts resulted in the successful development of an innovative training program that prepares community members to act as ambassadors and advocates for cancer screening and lifestyle information. Initially, the lifestyle- based program was directed towards breast health but has been expanded successfully as the Colorectal Health Research Champion (CHRC) program, implementing the NCI Screen to Save Program (S2S) as part of its curriculum. This proposal seeks to expand the CHRC program by creating alternative program delivery modalities that facilitate program delivery in person or virtually using short videos and e-health data capture, focus on rural communities within the catchment and adapt and pilot the CHRC program for delivery in Spanish. Given the extraordinarily high burden of colorectal cancer (CRC) incidence and mortality in rural, Southern Virginia, and the growing population of Spanish-speaking residents, the expansion of our efforts into this underserved area is critical. The proposed activities will build on the NON CHE S2S program and ongoing community outreach initiatives that have been successful reaching AA/Black residents of Petersburg and expand our model of community engaged outreach to Latino and rural underserved communities.

Public health relevance
Project Narrative Given the extraordinarily high burden of colorectal cancer incidence and mortality in rural, Southern Virginia continued outreach and education efforts into priority communities is critical. The proposed activities will build on the National Outreach Network Community Health Educator (NON CHE) Screen to Save program and ongoing community outreach initiatives that have been successful reaching African American/Black residents of Petersburg and expand our model of community engaged outreach to Latino and rural underserved communities. This work is helping to support the science of a community-focused outreach to reducing cancer health disparities and improve cancer-related outcomes.